The Experimental Energy Landscape and Protein Function

Our parent R01 is focused on investigating the role of local unfolding in mediating the biological function
of proteins, and a significant goal over the past 20 years of this grant has been the use of experimental
data to develop and refine our evolving model of protein structural fluctuations so as to investigate the
evolution of new function and disease. The goal of this project supplement is to capitalize on a recent
discovery directly stemming from this project, whereby we are able to identify the role of “antigen mimicry”
in the SARS COV-2 (the causative agent of COVID-19), which results in autoimmunity to specific proteins
in a subset of infected patients. Our unique approach is (to our knowledge) the only predictive model that
allows us to identify thermodynamic similarity between structurally and chemically different protein
sequences. We show that by generating a thermodynamic fingerprint for each protein product of the
SARs-COV-2 virus, we can compare the fingerprint with the fingerprints of the entire human proteome
and identify statistically significant matches. Our original hypothesis was that similar thermodynamic
fingerprints will be recognized by a common polyclonal antibody response. To challenge this hypothesis,
we identified a number of high-identity matches for numerous proteins of the SARS-COV-2, one such
example protein is orf10, which is predicted to share a signature with the human protein CD53. To directly
test this initial prediction, we utilized a commercially available “proteome on a chip” technology to screen
for the ability of orf10-specific polyclonal antibodies to bind with every expressed human protein.
Remarkably, polyclonal antibodies to orf10 cross-reacted specifically with CD53, thus validating
our hypothesis. As one possible disease etiology of “long-COVID” involves the high instances for viral-
induced autoimmunity, our approach is uniquely suited to address this issue mechanistically. Our
approach not only identifies which human proteins are similar with each viral protein and thus which are
potential candidates for auto-immunity, it also identifies the sequence elements most responsible for the
high similarity. This capability not only provides the medical community with a starting point to target
mechanistic studies, it allows us and others to investigate the effects of genotypic variation with the human
population. Here we will; 1) use our approach to identify all predicted matches between SARS-COV-2
proteins and the human proteome, and 2) experimentally test these predictions using commercially
available “proteome on a chip” technology. All of the computed matches and the experimental validation
data will be made available on our well-established web-server.

Public health relevance
Understanding the origin of autoimmunity of SAR-COV-2-infected patients is key to therapeutic intervention of “long-COVID”, where autoimmunity to certain human proteins has been identified. Development of a model that identify the link between SARS-COV-2 proteins and human proteins is a critical first step toward a mechanistic understanding. The studies proposed here are designed to fill the gap in knowledge by identifying which proteins in SARS-COV-2 are responsible for autoimmunity to specific human proteins.